Cellular lipid transport determined with multifunctional lipid derivatives

Summary
It is well understood how lipids are synthesized and metabolized in cells and that many lipids exhibit signalling functions
to regulate cellular processes in a spatially and temporally defined way. The latter requires the build-up and turnover of
lipid species in membranes either in a site-specific fashion or, alternatively, a directed form of lipid transport. This work
aims to investigate the intracellular transfer of lipids from one membrane to another by several proteins that we
discovered to be involved in lipid transport. In the previous funding period, we synthesized multifunctional lipid
derivatives of five phosphoinositides and four common glycerophospholipids. These feature a photo-activatable
protecting group (”cage”) to release the lipid derivative by light and a photo-crosslinking diazirine to covalently attach
the lipid derivative to binding proteins. An alkyne group for click chemistry is useful for isolating lipid-protein conjugates
or for determining the lipid location in cells by fluorescent tagging and microscopy. In published work, we identified
specific lipid binding proteins for phosphatidylinositol 3,4,5-trisphosphate (PIP3), phosphatidylinositol 3,4-bisphosphate
[PI(3,4)P2], and phosphatidylinositol (PI). Because the “caged” derivatives accumulated in endomembranes, we observed
changes in their subsequent cellular distribution after uncaging with light. All three phosphoinositides transferred to the
plasma membrane (PM) within 30 to 120 sec. Such transport is known for PI but has never been described for PIP3 or
PI(3,4)P2. We then identified putative lipid transport proteins via proteomic analysis and used siRNAs to block lipid
transport. We found two hits that were required for transporting PIP3 and PI(3,4)P2: cytosolic MPP6 and transmembrane
ATP11A. Knockdown of both reduced internalization of EGF receptor, indicating effects on PIP3 signalling. In this work,
we will characterize the lipid transport by these two proteins with respect to lipid specificity (Aim 1.1). For this aim, we
will improve our current method of precisely quantifying lipid transport in cells (Aim 1.2). We will validate our findings
in-vitro by using recombinant proteins including those with point mutations of key residues to study protein-lipid
interactions with biophysical and biochemical methods (Aim 1.3). We will increase rigor by analysing the cellular lipid
composition by mass spectrometry after uncaging lipid derivatives (Aim 1.4). In Aim 2, we will demonstrate the need of
MPP6 mobility for lipid transport. We will develop a light-switchable MPP6 using the LOV2 technique that will replace
endogenous MPP6 (by gene editing) and will be located at the plasma membrane (PM) until we illuminate the cells with
488 nm light. We hypothesize that lipid transport will only be possible if MPP6 is liberated from the PM. We will also test
for lipid retro-transport by MPP6 from the PM to endomembranes. For this, we will synthesize lipid derivatives that
accumulate at the outer leaflet of the PM and induce cell entry and transport via uncaging. In Aim 3, we will synthesize
lipid derivatives featuring the photo-crosslinking diazirine closer to the membrane interphase to reach more transiently
binding proteins such as those with a PH domain. Comparative proteomic analysis of the lipid interactomes will then be
used to identify proteins involved in signalling with and without receptor stimulation.

Public health relevance
Narrative We recently discovered a new way of how signalling lipids are transported in cells. We will fully characterize the components of this exciting new mechanism and will expand the investigations to many other cellular lipids. This work will be the basis for determining the relevance of our findings for cellular signalling and will ultimately identify new drug targets for treating diseases such as cancer and multiple sclerosis.